USEFULNESS OF ULTRASOUND CONTRAST MEDIA IN RADIOLOGY

Determine the benefit of contrast media for any patient whose ultrasound examination is thought to be insufficient to diagnose the disease and reveal the efficacy of contrast enhanced ultrasound in radiology field, including liver, kidney, spleen, trauma or whatever.